Networking Core: Houston Area Incubator for Kidney, Urologic, and Hematologic Research Training (HAI-KUH)

In accordance with the goals of the NIDDK U2C KUH training initiative, the Houston Area Incubator for Kidney,
Urologic, and Hematologic Research Training (HAI-KUH) will support the scientific training and career
development of a pipeline of researchers, equipping them with the skills needed to flourish in independent
careers across kidney, urologic, and hematologic (KUH) research missions. As part of this initiative, the
Networking Core reimagines interinstitutional scientific engagement within KUH fields in Houston’s Texas
Medical Center (TMC). The goal of the Networking Core is to facilitate and incentivize scientific interactions
across training stages, institutions, and KUH disciplines to foster multidisciplinary, collaborative research in a
supportive training environment. Additionally, by establishing innovative training on core networking
competencies, developing virtual platforms to support interaction with other KUH researchers locally, nationally,
and worldwide, and supporting engagement between trainees and the Houston community, the Networking Core
will promote career advancement and community interest in the KUH areas. In Aim 1, the Networking Core will
build an interactive and inclusive KUH research community within the Houston area by facilitating scientific
engagement and social networks by providing those in training pods developed by the Professional Development
Core and other KUH research trainees with regular networking events and an annual HAI-KUH symposium. It
will provide opportunities for community outreach through education seminars designed to promote public
interest in KUH research and interaction with other KUH U2C consortia. Aim 2 is to develop a cohort of KUH
trainees with strong networking skills through the Networking Core’s Networking, Engagement, and Social Media
Training (NEST) series. Networking training that spans valuable in-person, virtual, and social media-based
competencies will stimulate collaboration, as will an innovative competitive seed grant program based on new,
interinstitutional team science. Aim 3 will enable networking and interdisciplinary interaction by building on
trainee-led virtual platforms to develop a HAI-KUH site on the powerful, highly customizable Hivebrite platform.
The virtual community established through the site will support interactions within the HAI-KUH community,
including alums and KUH-research-related enterprises, and promote civic outreach. Additionally, HAI-KUH will
support novel proposals to transform networking and involve the public within the KUH research community. Aim
4 is to build a sustainable pipeline of future KUH researchers by synergizing with the large, established STEM
outreach and career development programs in the TMC by creating HAI-KUH-specific tracks. Working together
with the Professional Development and Training Cores, the Networking core will integrate trainee feedback and
refine the objectives to align with the goals of HAI-KUH. HAI-KUH will ultimately build the KUH research target
areas defined by the NIDDK by filling a critical need for community KUH education and engagement through the
Networking Core.
0

Public health relevance
The Houston Area Incubator for Kidney, Urologic, and Hematologic Research Training (HAI-KUH) aims to develop a highly qualified workforce of dedicated research professionals to improve the health and quality of life of patients with nonmalignant kidney, urologic, and hematologic diseases. Through our robust network of KUH researchers from multiple Houston institutions and a variety of scientific backgrounds, we will collaborate to not only expand existing efforts but seize the opportunity to support a range of career paths, promote interdisciplinary research, and bring training excellence to graduate students and postdoctoral and clinical fellows to KUH mission areas.